Spatiotemporal Coding in the Pain Circuit Along the Spine-brain Continuum

Summary/Abstract
Pain is a national health challenge costing our economy more than $600 Billions per year. Faced with
ineffective therapies, millions of patients are being over-prescribed opioid-based medications, which is
contributing to addiction and lethal overdose.
This application is in response to RFA-NS-18-009 “BRAIN Initiative: Targeted BRAIN Circuits Projects
(R01)” which calls for “Innovative approaches and new paradigms for identifying and understanding
nociception and pain in the context of circuit mechanisms of the central nervous system”.
We propose AIM 1) tool development to test the hypothesis that Laminae II/III PV neurons inhibit
nociceptive relay neurons in vivo, AIM 2) behavioral development to validate a novel model for rapid reporting
of sensory stimuli, and AIM 3) combination of real-time neural recording from the spine-brain continuum and
ecological behavior to test the hypothesis that distinct rhythms in sensory thalamus and neocortex are
temporally correlated with tactile and noxious stimuli. Moreover, excitation of PV neurons inhibits thalamic
neurons and modulates thalamocortical rhythms.
These aims will be investigated using laboratory animal models of pain and state-of-the-art techniques for
simultaneous recording from multiple areas in the spine cord and brain, combined with cell-speciﬁc stimulation
in the periphery using optical methods in awake rodents. Therefore, this application will enhance our scientiﬁc
understanding of pain mechanisms in the central nervous system and potentially lead to novel diagnostic and
therapeutic approaches.

Public health relevance
Project Narrative This project proposes to investigate the basic mechanisms of nociception and pain in the spinal cord and brain of awake animals. Therefore, data generated by this proposal will enhance our understanding of the basic mechanisms of neural circuits in the “spine-brain continuum” in health and disease conditions of neuropathic pain, using pre-clinical animal models of translational relevance to humans.